Megabase Scale Genome Engineering and Synthesis in Mammalian Cells

Megabase Scale Genome Engineering and Synthesis in Mammalian Cells Project Summary: The design and synthesis of entire genomes provide a powerful strategy for understanding biology and developing medical applications. However, there is currently limited capacity to perform genome modifications at very large scale in general, and especially in mammalian systems. Despite limited successes in yeast and bacteria (Saccharomyces cerevisiae, Mycoplasma, Escherichia coli), the current state of the art in the field of genome synthesis faces three major challenges: i) how to join synthetic DNA fragments into a very large contiguous assembly, ii) how to deliver the very large synthetic assembly into the host cell, and iii) how to integrate the delivered synthetic DNA into defined genomic locations at very large scale. In addition, both i) the “synthetic minichunk” based integration strategy developed for chromosome synthesis in S. cerevisiae, and ii) the “genome transplantation” method to replace the entire genome of Mycoplasma species in a single step, depend on special properties of the host organisms, and thus are unlikely to work in mammalian systems. As a result, the current progress in large-scale mammalian genome modifications is limited to two examples of locus- replacements. Building on my previous success in the total synthesis of a 4-mb recoded E. coli genome, the current pinnacle across all systems, my newly established lab at Caltech aims to take the next step by expanding such state-of- the-art genome-writing capacities into mammalian systems. I propose to develop next-generation technologies to overcome all three challenges aforementioned by enabling: i) megabase assembly of synthetic DNA in bacteria designed for mammalian expression and subsequent delivery, ii) megabase delivery of synthetic DNA into mammalian host cells via engineered endosymbiotic bacteria, iii) megabase integration of delivered synthetic DNA into defined chromosomal locations with high theoretical size capacity and efficiency. The three aspects of this work (megabase assembly, delivery, and integration of synthetic DNA) are all crucial for the field of genome synthesis. Combined together, this work aims to establish megabase or larger scale genome-writing capacities in mammalian systems, and to pave the foundation for the de novo synthesis of an entire mammalian chromosome and ultimately the entire genome. Once achieved, such revolutionary platform technologies can significantly accelerate or even transform a wide range of biological and biomedical areas including ? but not limited to ? gene therapy, CAR T-cell immunotherapy, humanized animal models, humanized antibody development, xenotransplantation, and epigenetic studies.

Public health relevance
Megabase Scale Genome Engineering and Synthesis in Mammalian Cells Project Narrative: Having the ability to design and construct entire genomes may play a critical part in our fundamental understanding of biology and in transitioning synthetic biology technologies into the clinic; however, robust methodologies to synthetically modify mammalian genomes at megabase or larger scale has remained elusive. Building on my success in the total synthesis of a 4-mb recoded E. coli genome, I aim to expand such pioneering capacities into mammalian cells. To achieve this goal, I propose to develop paradigm-shifting technologies to assemble, deliver, and integrate very large (³mb) synthetic DNA into mammalian genomes, with the eventual goals of total synthesis of an entire mammalian chromosome and ultimately the genome.